Kansas City Clinical Oncology Program

DESCRIPTION (provided by applicant): The Kansas City Clinical Oncology Program (KCCOP) expects to transition to NCORP-KC. It is a very successful non-profit organization conducting clinical trials in cancer therapy, cancer symptom prevention. Quality of Life, and cancer control since 1983 with uninterrupted funding by the National Cancer Institute. The program is located in the Kansas City metropolitan area and serves the needs of both Kansas and Missouri residents spread over 16 counties and 2.5 million citizens. The program is comprised of seven component area hospitals and 52 investigators representing specialties well beyond medical, surgical, gynecologic, and radiation oncology. The other areas of expertise include outcomes research, internal medicine, healthcare administration, healthcare informatics, behavioral science, rehabilitation and survivorship, palliative care, neurology, gastroenterology, genetic counseling, pathology, cellular therapy, laboratory science, and radiology. The program has provided participation opportunities to over 4,200 patients and volunteers in cancer-related trials since its inception. Over the last five years, an average of 235 new individuals have participated per year. The program has maintained excellent quality of research as confirmed by patient satisfaction and reports from external audits. The program derives its cancer trials from SWOG, NRG, ALLIANCE, CTSU, MD Anderson, URCC, and SunCoast research bases of the National Cancer Institute. NCORP-KC wishes to thank its participants and extend its service by entering a new era of Cancer Care Delivery Research while continuing to conduct high quality trials in cancer therapy, cancer control, screening, imaging, and post-therapy surveillance. The program monitors trends and implements measures for continued improvement. It balances protecting patients, their safety, and health with providing the broadest possible access to trial activation and minority outreach participation with the help of a highly responsive and responsible support staff.

Public health relevance
PUBLIC HEALTH RELEVANCE: NCORP-KC supports the mission of the National Cancer Institute in accelerating the development of personalized therapies for cancer, minimizing or controlling symptoms related to therapies, identifying risk factors for cancer, and developing technologies for the early detection and prevention of cancer. NCORP-KC will achieve this by fostering a widespread participation of all stakeholders in clinical trials and cancer care delivey research. It will reach out to the entire Kansas City metropolitan area while promoting the participation of minorities, the elderly, and the underprivileged.